Regulatory mechanisms for the biogenesis and polymerization of alpha/beta tubulin and their impact on Microtubule Function

Project Summary
The dynamic microtubule cytoskeleton mediates intracellular organization, generates forces for
dividing or migrating eukaryotic cells, and forms tracks for intracellular trafficking. The fundamental
properties of microtubules, including polarized growth and “dynamic instability” stem directly from the
activities of their building blocks, the αβ-tubulin heterodimers. Tubulins are among the most highly
expressed proteins in eukaryotic cells. Despite advances in understanding special mechanisms
regulating tubulin translation and folding, we lack understanding of how -tubulins are topologically
assembled by three conserved tubulin cofactors (C, D, and E) and the dedicated Arf-like 2 G-protein.
These molecules form multi-subunit platforms for the GTP-hydrolysis-dependent biogenesis and
degradation of αβ-tubulins and maintain their high concentration within the cytoplasm. However, the
mechanisms of these assemblies remain mostly mysterious, due in part to a lack of biochemical and
structural information. We do not understand how the unique microtubule polymerization regulators,
chTOG and CLASP, with arrays of tumor overexpressed gene (TOG) domains, recruit -tubulins
while persistently tracking dynamic microtubule ends. Understanding these cellular regulation
pathways is critical since genetic defects that impair either soluble -tubulin biogenesis or
microtubule regulators are linked to inherited neurological and developmental disorders and are
observed in human cancers, respectively. This proposal explores the biochemical and structural
mechanisms of -tubulin biogenesis and microtubule polymerization regulators and their impact on
microtubule function. Our strategy combines methods across multiple resolution scales, including in
vitro reconstitution of purified assemblies, structural studies by cryo-electron microscopy (cryo-EM),
reconstitution of assemblies with microtubule dynamics using in vitro fluorescence microscopy-based
assays, and in vivo live imaging within living cells in collaboration with two expert cell biology groups.
In the first research theme, we will build on our recently determined cryo-EM structures for yeast
tubulin cofactor Arf-like 2 assemblies with -tubulin in the pre- and post-catalytic states to explore
the biological roles of assembly interactions using an in vivo model system for -tubulin biogenesis,
and we will determine novel cryo-EM structures for human tubulin cofactor assemblies purified from
eukaryotic cells bound to novel monomeric tubulin biogenesis intermediates. These studies will fill in
missing structural states and establish the functional relevance of the “catalytic chaperone” -tubulin
biogenesis model. These studies will also deepen our understanding of how -tubulin biogenesis is
regulated and its functional impact on microtubule function. In the second research theme, we will
build on our understanding of the role of the self-folding of yeast TOG arrays in the recruitment and
polymerization of -tubulin by using a new strategy to reconstitute human chTOG and CLASP,
bound to -tubulins in different states and determine their cryo-EM structures, and explore the
functional impact of these self-folded states using structure-based mutants using in vitro
reconstitution and in vivo novel CRISPER-based replacement and imaging in human cells. We will
expand on the “polarized unfurling” model we developed based on structural and biochemical studies
for the self-folding TOG domain arrays in mediating -tubulin recruitment and polymerization. These
studies will help determine the biochemical states of the two classes of microtubule regulators with
TOG domain arrays in regulating tubulin recruitment and promoting polymerization. Our focused
biochemical strategies will allow cryo-EM structure determination of assemblies in unique states that
will help refine and deepen our new models for soluble -tubulin biogenesis, TOG array-mediated
recruitment, and incorporation of -tubulin during microtubule polymerization. Our studies will pave
the way to a deeper understanding of tubulin regulation, which will in turn point toward new strategies
for addressing defects in tubulin biogenesis and regulation in patients with a range of developmental
and neurological disorders.

Public health relevance
Project Narrative: This project is highly relevant to public health as it focuses on understanding mechanisms of quality control pathways regulating cellular tubulin reserves, necessary for all microtubule dynamic polymerization activities, which are critical for human cell to form shape, crawl, duplicate during development. Genetic defects that impair tubulin or these quality control pathways are linked to inherited neurological and developmental disorders, including Lissencephaly, encephalopathy and Giant Axonal neuropathy. A deeper biochemical and molecular understanding of these pathways will be critical to developing effective strategies to address these inherited disorders, and could also highlight ways to control the growth of tumor cells by inhibiting microtubule dynamics.